Biomarker and Neurogenetics Core

Biomarker and Genetics Core, Abstract:
The Biomarker and Neurogenetics Core (BNGC) of the University
of Pittsburgh, Alzheimer’s Disease Research Center (PITT-ADRC) and its faculty has a long-standing history of
collection of biospecimens, beginning in 1994, and advancement of genetic and biomarker discovery in
Alzheimer’s disease and related diseases (ADRDs). In addition to collecting blood samples from PITT-ADRC
participants, we collect and bank blood samples from non-ADRC ancillary studies that provide additional well-
characterized older controls essential for our work and endophenotype data that would help to identify novel
genes and biomarkers for dementia. Over the last three decades, we have accumulated DNA and plasma
samples along with endophenotype and biomarker data from approximately 13,000 ADRC and non-ADRC
participants.
The recent development of high performances plasma biomarkers as the potential next generation of ADRD
diagnostics for monitoring amyloid-beta plaque (Aβ; A) and tau neurofibrillary tangles (T) pathologies as well as
neurodegeneration (N), has become a new focus of the BNGC during the last three years. Using the PITT-ADRC
deeply phenotyped banked plasma samples, we have now begun studies on 4500 unique participants who will
concomitantly have information on plasma Aβ, phosphorylated tau, glial fibrillary acidic protein (GFAP), brain-
derived tau (BD-tau) and neurofilament light chain (NfL). Moreover, the participants have available neuroimaging,
neuropathology and genetic data that will allow the BNGC to ask critical questions related to the performance of
these biomarkers and their relationships to our well-established studies on pathology and genetic risk.
In this renewal, the BNGC will address questions related to the role of genetic architecture, demographics,
and comorbidities on the performance of plasma biomarkers and their clinical utility in alignment with the PITT-
ADRC theme “From Neighborhoods to Neurons”. The BNGC will continue to maintain a database of fluid
biomarker and genetic data as well as a biorepository containing plasma and DNA samples, both of which are
available broadly to the research community. We will utilize archived plasma samples to examine the analytical
robustness of AT(N) plasma biomarkers, and determine cut-points against paired neuroimaging and cognitive
assessment results.